Engineered Pan-Specific Reagents for N-Glycan Detection and Enrichment

PROJECT SUMMARY
Glycans play crucial roles in nearly every aspect of biological processes, and their distinct properties make
them appealing as disease biomarker targets. However, due to their highly branched and variably linked
nature, glycans pose a challenge for detection, purification, and structural analysis. Although advanced
analytical techniques and instrumentation have been developed that target glycans, there is still a great need
for reagents with well-defined carbohydrate specificity and high affinity that can be used to independently
interrogate or enrich carbohydrate samples prior to traditional analyses.
Lectenz Bio has been engineering glycan-processing enzymes and glycan-binding proteins into high-affinity
glycan-specific reagents with tunable properties. The Fbs1 component of the E3 ubiquitin ligase complex
recognizes glycans as part of its biological role in ubiquitylation. It is therefore a promising protein for
conversion into a binding reagent for asparagine-linked glycans (N-glycans), which we will achieve by
employing computational modeling and directed evolution. Initial studies demonstrate that Fbs1 can be readily
expressed in E. coli, and binds specifically to N-glycosylated peptides and proteins, and not to the
corresponding non-glycosylated peptides and proteins. However, it does demonstrate a preference for certain
N-glycan structures.
A pan-specific N-glycan binding reagent would directly address the urgent need to tools to help detect glyco-
biomarkers and could immediately benefit the field of glycomics/glycoproteomics by enabling sample pre-
enrichment. After engineering and optimizing the production of recombinant Fbs1 and its engineered variants,
Lectenz Bio will develop a suite of kits for its application in Western blotting, immunohistochemistry, ELISA,
flow cytometry, and affinity chromatography.

Public health relevance
PROJECT NARRATIVE Because altered glycosylation is a signature of many diseases, including cancer, infection, and neurodegenerative disorders, there is a need for reagents with high affinity and specificity for detecting glycans. We will optimize the specificity of Fbs1 for glycopeptides and glycoproteins that contain asparagine- linked (N-linked) carbohydrate chains using computationally-guided directed evolution. The resulting reagent will have broad utility in glycoscience research, including glycomics and glycoproteomics.